DEVELOPMENT OF RABBIT MONOCLONAL ANTIBODIES FOR FERRET BIOMARKERS

This project is to generate and characterize rabbit monoclonal antibodies (mAbs) against five ferret biomarkers, focusing on inflammatory cytokines produced following immune activation in ferrets. Generated mAbs will undergo extensive immunological characterization. The successful completion of this project will address an urgent need for specific and sensitive reagents capable of measuring cytokine responses in the ferret model for infectious disease and immunology research.